Temporal interference methods for non-invasive deep brain stimulation

Project summary/abstract (30 lines max)
A number of clinical disorders such as addiction, OCD, and schizophrenia, as well as neurological disorders
including Parkinson’s disease, depend critically on deeper brain regions. Invasive deep brain stimulation of the
nucleus accumbens, for example, has been shown to cause rapid, effortless loss of addiction, but these
interventions are impractical due to the risks and costs of brain surgery. There is currently no developed non-
invasive method of deep brain stimulation -- existing methods such as TMS, tDCS, tACS, and tFUS do not
stimulate deep brain regions without also stimulating the overlying cortex, causing unwanted side effects and
confounds. Moreover, there is unresolved debate about the causal role of deeper brain regions in cognition, as
methods like fMRI show correlations but not causation between brain activity and behavior. This project
explores temporal interference (TI) electrical neurostimulation as a potential new technology to test causal
hypotheses about deep brain function in human cognition, which may further provide a foundation for treating
clinical disorders involving deeper brain regions. TI works by applying two or more high frequency alternating
current fields of slightly different frequencies. The fields individually do not stimulate brain activity, but where
the fields overlap, there is a pattern of temporal interference which can activate neurons. Using combined TI
and fMRI in human subjects, we will characterize the effect of TI on BOLD signals and functional connectivity,
and how those vary with different TI frequencies and targeted brain regions (Aim 1). Then we will apply TI to
the dorsal anterior cingulate cortex (dACC), to resolve longstanding debates about the causal role of dACC in
cognition, especially in conflict monitoring, risk avoidance, and foraging behavior (Aim 2). The results will
establish TI as a means of safely and effectively manipulating deep brain activity without activating the
overlying cortical regions. This in turn will provide a new method for answering questions about the causal role
of various deeper brain regions in cognition as well as a new means of treating clinical disorders involving
deeper brain regions.

Public health relevance
Project narrative There is an urgent need to develop non-invasive focal deep brain stimulation methods, especially with the potential to be cost effective and portable. Temporal interference electrical neurostimulation promises to provide such a technology, but its effects on human brain activity and behavior are relatively unknown. This project will test temporal interference neurostimulation in humans with fMRI and explore its usefulness in resolving longstanding debates about the causal role of deeper brain regions in cognition, paving the way for future clinical studies to treat addiction, OCD, and other clinical issues that depend on deeper brain regions.